RNA methylation as a novel effector of SETD2 in kidney cancer

ABSTRACT
Clear cell renal cell carcinoma (ccRCC) accounts for ~75% of kidney cancers and is the 8th leading
cause of cancer death in the United States. In addition to near ubiquitous loss of VHL, the landscape of ccRCC
is dominated by mutations in epigenetic regulators SETD2, PBRM1, and BAP1. The epigenome is profoundly
disrupted in ccRCC with defects in epigenetic marks on DNA, RNA, and histones, culminating in aberrant gene
expression. Mutations in the SETD2 histone H3 lysine 36 trimethylase occur in ~25% of primary ccRCC but
increase to >60% in ccRCC metastases. Completion of TCGA enabled identification of actionable mutations in
virtually every solid tumor and those profiles now drive treatment decisions. One major exception, however, is
RCC, where the current standard of care, checkpoint inhibitor and anti-VEGF therapy, does not account for
~50% of RCCs having mutations in chromatin regulators like SETD2. Many ccRCCs display heterogeneous
and subclonal intratumor SETD2 mutations, but we do not understand how SETD2 loss deregulates cell
growth and what pathways it works through. After first-line therapy, response rates are 20%, highlighting the
need to understand and target drivers of metastasis like SETD2. A recent novel finding linked SETD2 activity
to the targeting of N6-methyladenosine in mRNA, a key mechanism for controlling many RNA metabolic
processes, which has also been shown to be deregulated in cancer and contribute to metastatic processes.
Our preliminary data demonstrate that SETD2 loss leads to large-scale re-localization of m6A and an
enhanced sensitivity to an m6A inhibitor that is entering clinical trials. This SETD2-m6A link has not been
explored in a ccRCC context but could represent a novel SETD2 effector mechanism and drug target in
ccRCC. We explore this relationship for the first time with this pilot R21 study, making it directly relevant to
NOT-CA-23-060, RNA Modifications in Cancer Biology. Our proposal is significant because ~30% of patients
diagnosed with clinically localized RCC experience metastatic progression, and once metastatic disease
develops only ~7% survive >5 years. Our central hypothesis is that loss of SETD2 drives aggressive ccRCC in
part through deregulated m6A targeting that promotes a pro-metastatic expression program. Our proposal is
expected to develop relevant ccRCC cell line models and define the links between SETD2/H3K36me3 and
METTL3/m6A in ccRCC through the following specific aims. In aim 1, we will map H3K36me3, m6A, METTL3,
and expression patterns using RIP-/ChIP-/RNA-seq in novel SETD2 isogenic renal cell line models. In aim 2,
we will perform integrative analysis of omics data to uncover genes/pathways impacted by SETD2 loss in an
m6A-dependent manner. Finally, in aim 3 we will genetically and pharmacologically modulate m6A in SETD2
isogenic cell lines and define cancer-relevant cellular growth phenotypes. This work is expected to positively
affect human health by yielding a new understanding of the mechanistic underpinnings of SETD2 driven cell
growth deregulation and uncovering new ways to therapeutically target this mutation.

Public health relevance
NARRATIVE Clear cell renal cell carcinoma (ccRCC) is currently the 8th leading cause of cancer death in the United States and is unusual for its high frequency of epigenome regulator gene mutations, including a gene called SETD2 that when mutated, is associated with reduced survival and metastasis. SETD2 may regulate a novel mechanism that controls mRNA level and stability known as RNA methylation. This is exciting not only because it could represent a new way SETD2 loss drives cancer growth, but also because drugs are being developed to target RNA methylation that might be effective in treating SETD2 mutant renal cell cancer.